Nutrition Shared Resource

NUTRITION SHARED RESOURCE: ABSTRACT

The Nutrition Shared Resource (NSR) co-directed by Debra Sullivan, PhD, RD, and Jill Hamilton-Reeves, PhD, RD, CSO, facilitates an important aspect of addressing the cancer risk factor of obesity as a priority area for The University of Kansas Cancer Center (KUCC) by providing support for basic, clinical and population health research evaluating the effects of nutrition on cancer therapies, cancer prevention and cancer population health. The NSR offers quantitative measurements of dietary intake, physical activity, nutrition status/malnutrition assessments, standardized diets, body composition, microbiome, and nutrition literacy. NSR services also include design and implementation of interventions to adhere to specific diet or physical activity goals. The NSR provides expertise in oncology nutrition, diet assessment, intervention design, energy balance, body composition, gut microbiome, and nutrition literacy. The faculty and staff of the NSR oversee the measurements and/or services as required for each study. NSR maintains licensed copies of the Nutrition Data System for Research (NDS-R) and Nutrascreen for dietary intake assessments. The NSR maintains software and instrumentation such as the sliceOmatic, DXA, Bod Pod, Tod Pod, and Pea Pod, and the Bodystat Quadscan 4000 bioelectrical impedance analyzer to assess body composition across the lifespan or at the bedside/clinic for cancer therapeutic trials. Handgrip dynamometers and skin carotenoid meters are other instruments frequently used for nutrition assessments. Services are provided on-site at the KU Clinical Research Center (CRC), Westwood and KU Hospital locations, as well as via outreach to Masonic Cancer Alliance (MCA) partners, sites across the KUCC catchment area, and external NCI-designated cancer centers. The NSR collaborates with communities throughout the catchment area using community screenings and outreach. The NSR was a key resource for KUCC adapting obesity as a priority area. The NSR has grown from its inception in 2016 from a developing shared resource to a full shared resource. During this development phase, NSR annual usage grew from zero to 30 KUCC members with a total of 61 distinct members across all programs. In the reporting year (2020), the budget of the NSR is $959,579. The NSR has robust peer-supported funding with 83% of the budget supported by other grants. The NSR trains and educates the next generation of oncology scientists and health care professionals through collaborative research and outreach efforts with the MCA. The NSR regularly incorporates trainees at all levels within projects and prioritizes support for early-stage investigators.